Delineating sex-specific abstinence-induced negative affective behavior in insular circuitry

Project Summary/Abstract
Alcohol Use Disorder (AUD) is a growing problem in our nation and worldwide. The COVID-19 pandemic has
led to a significant increase in alcohol use, with a particularly sharp rise in women, with many people
relapsing due to the negative affective states correlated with abstinence. A functional connectivity network of
abstinence-induced negative affect is needed to fully understand these states in order to better help people
suffering with AUD. Previous work in our lab has elucidated parts of the pathway, delineating an insula to
BNST pathway that is activated during alcohol abstinence induced negative affect by testing male and
female though locomotor based behavioral assays. Due to findings in recent literature, however, it is
possible that these locomotor-based assays do not reveal the full scope of negative affective behavior in
female mice. The applicant, Amanda Salazar, proposes to build on the experiments in the parent grant to
test a non-locomotor based behavioral assay that has not been tested in our CDFA model, and is therefore a
logical extension of the parent grant. This will allow us to properly identify sex differences in negative affect
in mice during alcohol abstinence. We hypothesize that female mice will exhibit a much stronger alcohol
abstinence-induced negative affect-like phenotype in startle response tests (acoustic, air puff, foot shock)
compared to male mice. Amanda will build off her molecular biology background to gain meaningful training
in alcohol models, stereotaxic surgery, fiber photometry, and statistical analysis and presentation of data.
Mentorship will also focus on furthering scientific communication skills and engaging in outreach within the
lab, the program, and the community to reach her goal of admittance into a PhD program

Public health relevance
Project Narrative Negative affect is a major driver of relapse in individuals with an alcohol use disorder (AUD), with women representing a significant increase in this area. Currently, our understanding of a functional connectivity network of abstinence induced negative affect is lacking. The successful completion of the proposed studies by the trainee would result in important new training and career development for her, as well as provide new information regarding abstinence-induced negative affective states in a sex-specific manner, thus increasing the impact of the parent grant and possibly creating new avenues of treatment for those suffering from AUD.